Mitochondrial magnesium regulates MCU activity and PTP opening during ischemic reperfusion injury

PROJECT SUMMARY
Magnesium (Mg2+) is a ubiquitous intracellular divalent cation and a crucial co-factor in the machinery that
replicates, transcribes, and translates genomic information. Like calcium, Mg2+ is compartmentalized to
mitochondria, and Mrs2 is the only known molecular machinery associated with mitochondrial Mg2+ influx. Apart
from its conventional function of activating enzymes within the TCA cycle and electron transport chain, our
previous research showed mitochondrial Mg2+ (mMg2+) to bind the N-terminal domain of the mitochondrial Ca2+
Uniporter (MCU) regulating acidic patch (MRAP) and regulates MCU-mediated mitochondrial Ca2+ (mCa2+)
uptake. The overload of mCa2+ is associated with heart failure (HF) and because mMg2+ regulates mCa2+ uptake,
we anticipate a loss of mMg2+ homeostasis in ischemic reperfusion (IR) injury, which can overload mCa2+ and
predispose the cardiomyocytes to mitochondrial permeability transition pore (mPTP)-mediated cell death. Our
preliminary results indicated a significant reduction in mMg2+ uptake in NRVMs exposed to
hypoxia/reoxygenation relative to the control. Intriguingly, the decrease in mMg2+ was not due to a decrease in
mRNA or protein levels, but rather post-translational modification of Mrs2 by oxidation, resulting in a loss of
function. Our preliminary results also showed that the loss of mMg2+ uptake was related to increased mCa2+
overload, bioenergetics crisis, and mPTP opening. To determine whether impaired mMg2+ influx causes mCa2+
overload and mPTP opening, we expressed a cysteine null (Mrs2C269A) mutant in NRVMs. We observed that
cysteine nullification rendered Mrs2 insensitive to oxidation and oxidative inhibition, protecting NRVMs from
mCa2+ overload-mediated cell death during HR injury. Based on these observations, we hypothesize that
oxidative stress inactivates Mrs2, resulting in the loss of mMg2+ uptake. This, in turn, relieves MCU from Mg2+-
dependent negative feedback inhibition, ultimately leading to an increase in MCU-mediated mCa2+ overload and
making cardiomyocytes more susceptible to mPTP-mediated cell death. To evaluate whether impaired mMg2+
influx is causally linked to mCa2+ overload-mediated cardiomyocyte death and heart failure, we propose three
aims: Aim 1: Define the mechanism by which post-translational oxidative modification regulates Mrs2 activity.
Aim 2: Investigate the regulatory role of Mrs2 oxidation in cardiac mitochondrial bioenergetics. Aim 3: Define
the ionic link between Mrs2 and MCU in regulating cardiac function during IR injury. The completion of the
proposed experiments will provide a missing link between the "ionic dysregulation" and "mitochondrial
dysfunction" hypotheses and advocate targeting mitochondrial ion homeostasis as a powerful therapeutic
strategy to inhibit or reverse HF progression, even though the role of mCa2+ overload and mPTP opening in
cardiac diseases are already known.

Public health relevance
PROJECT NARRATIVE Though evidence exists on the mitochondrial calcium to induce mitochondrial permeability transition pore opening and cell death in heart failure, the underlying molecular mechanism remains elusive. Results from our study will be the first of its kind to show how the interplay between mitochondrial Mg2+ and mitochondrial Ca2+ causally contributes to cardiac dysfunction.